MBRS SCORE Program at The Ponce School of Medicine

[unreadable] DESCRIPTION (provided by applicant): In this application we are requesting funds to support two regular subprojects in the MBRS SCORE Program at the Ponce School of Medicine. The goals of our MBRS SCORE Program are to: 1) increase the biomedical research productivity, 2) enhance the scientific competitiveness and recognition of the faculty, 3) provide first rate research and development opportunities, and 4) create a stimulating research atmosphere at the institution. The present supplemental application contains two regular subprojects. These initiatives are both basic and clinical research activities from faculty from the departments of Biochemistry and Microbiology. The diverse projects include areas in epidemiology, immunology, vaccine development, and molecular biology. These research projects will be sustained by an administrative component and by technical and personnel support that includes collaborators, consultants, and laboratory technicians. In addition, some of the activities will be complementary to other minority targeted programs in the institution such as RCMI Program, the Howard Hughes Medical Institute Science Education Initiative for Biomedical Research Institutions Programs, the Health Career Opportunity Program (HCOP) and, eventually the MBRS RISE Program. Progress in the Specific Aims of each project and in the overall aims of the Program will be evaluated yearly in a formative report and at the end in a summative document. Progress and achievements of the Program will be assessed continuously through an ongoing formative evaluation intended to provide information to improve the performance in the various program subprojects. A summative evaluation will finally assess the Program's success and the extent to which the completed projects have met their goals. Both the evaluation of the implementation, to assess whether the Program is being conducted as planned, and of the process, the assessment and the progress being made by the participant in meeting the individual subprojects and program goals, will be performed. [unreadable] [unreadable]